FUMA 3008: 28 DAYS ORAL 5FU + 776C85 VERSUS IV 5FU + LEUKOVORIN IN COLON CANCER

This randomized open label Phase III study aims to compare the safety, efficacy and duration of survival in patients with metastatic colorectal cancer who are treated with a 28 day oral regimen of 776C85 plus 5-FU or a five day regimen of intravenous 5-FU plus leukovorin. Response rates, duration of progression-free survival, quality of life, and medical resource use will also be compared between the two regimens.